Regulation of NKCC2 isoforms and blood pressure by tumor necrosis factor-alpha

We previously showed that tumor necrosis factor-alpha (TNF) produced within the kidney is part of a
mechanism that regulates renal function and the blood pressure (BP) response to increases in dietary salt
intake. Our recent studies suggest that TNF effects in the kidney are evident in the medullary (m) thick
ascending limb (TAL), proximal tubule (PT), and cortical (c) TAL/macula densa (MD) regions of the nephron.
However, the cellular sources within the kidney that produce the TNF that accounts for these effects have not
been determined, nor have the molecular mechanisms been identified. Thus, we developed two mouse
models in which TNF has been genetically deleted in the: 1) TAL, and 2) distal nephron downstream of the PT,
which will be used to understand the role of TNF produced by renal epithelial cells as part of an emerging
intratubular TNF system that attenuates increases in BP induced by high salt (HS) intake. We also have
tailored a complementary approach, using PT- and TAL-specific TNF silencing lentivirus constructs, to
specifically inhibit TNF production by these cell types. The genetic and lentivirus approaches will be used in
tandem to determine the mechanism by which TNF regulates Na+-K+-2Cl- (NKCC2) phosphorylation and
isoform expression, renal function, and BP. Preliminary data suggest that TNF, via activation of TNF receptor
1 (TNFR1), inhibits phospho-NKCC2 (pNKCC2) expression by a mechanism involving activation of the
serine/threonine phosphatase, calcineurin (CN). The effects of TNF on CN have not been explored in the
kidney, thus experiments will address TNF-dependent increases in CN activity as well as expression of the
catalytic subunit CNAb and regulatory subunit CNB. The genetic and lentivirus strategies will be adapted to
determine the effects of salt intake on TNFR1-dependent CN-mediated inhibition of pNKCC2 expression,
electrolyte excretion, and the BP response to HS intake. The NKCC2A and NKCC2B isoforms are strategically
localized along the mammalian TAL and contribute to regulatory functions in response to high and low salt
conditions, respectively. TNF inhibits the expression of both isoforms suggesting a role for this cytokine in both
the mTAL and cTAL/MD segments of the TAL. We previously showed that in each instance, TNF regulates
renal function involving these isoforms in a manner that limits reabsorption of NaCl. However, the molecular
mechanism by which TNF suppresses both NKCC2A and NKCC2B mRNA in response to high and low salt
intake, respectively, has not been determined. Previous miRNA profiling of the TAL in combination with new
preliminary data have identified 3 candidate miRNAs that regulate NKCC2 isoform mRNA abundance. For
instance, miRNA-195 expression is induced by TNF derived from the TAL and inhibits NKCC2A mRNA
accumulation and pNKCC2 expression in mice ingesting HS. Collectively, the studies will define a novel
intratubular regulatory system in which TNF production by renal tubular epithelial cells, in response to
increases in salt intake, regulates NKCC2 isoform expression and function and contributes to BP homeostasis.

Public health relevance
Hypertension is an important risk factor for the development of heart disease, stroke, and kidney disease that affects greater than 40% of the population in the United States. Many hypertensive patients, especially African Americans, exhibit sensitivity to salt. Exaggerated stimulation of ion transporters in the kidney of these individuals increases the retention of salt, which heightens elevations in blood pressure associated with an increase in dietary salt intake. Our study will determine the mechanisms that regulate an intratubular TNF system that is activated in renal epithelial cells in response to increases in dietary salt intake and attenuates salt-dependent increases in blood pressure.